Engagement of Students via Environmental Section Activities at the 2018 APHA Annual Meeting

PROJECT SUMMARY The 146th Annual Meeting and Exposition of the American Public Health Association (APHA) will be held from November 10 - 14, 2018 in San Diego, California. The theme for this year's conference, with an anticipated attendance of over 12,000 in total, is Creating the Healthiest Nation: Health Equity Now. APHA is a large organization, with a total membership of over 25,000. Therefore, while there are overarching sessions to appeal to the broader membership, each of its 27 sections plan the majority of the conference sessions and special events. The section-organized sessions and events focus on the interest areas of the section-specific membership. One of these 27 sections is the Environment Section, which focuses on environmental health issues. The Environment Section's goal for the 2018 APHA Annual Meeting is to foster interest in environmental health, increase student involvement, and to provide educational offerings on a wide range of environmental health topics, especially related to environmental justice. Ultimately, the Section strives to offer a wide variety of sessions, posters, plenary sessions, and special events to a diverse audience, representing academics, health professionals, community members, and students, especially those from underrepresented groups. To this end, our specific aims for this R13 proposal are: 1) To begin to build the next generation of environmental health leaders by providing a mechanism for underrepresented students to attend the meeting and; 2) To encourage mentorship between students and public health professionals, particularly around environmental justice; 3) To connect students receiving funding through this mechanism to a forum (i.e. a community of practice) for dissemination of results about research in environmental justice and environmental health. In its 107th year organizing sessions at the annual meeting, the Environment Section is focusing this year's agenda on environmental justice, with a particular focus on how disadvantaged, vulnerable, and underserved populations face disproportionate impacts of environmental exposures and associated health outcomes. To that end, we will use our extensive national network of academic, governmental, and community-based organizations and other consortia, to help promote this funding opportunity in order to recruit students from the underrepresented populations. We propose to engage and involve more students enabling them to connect with potential mentors, and to researchers, and to learn about community-based environmental justice initiatives and leaders.

Public health relevance
PROJECT NARRATIVE The program for the Environment Section at the 2018 American Public Health Association Annual Meeting will benefit participants, in particular underrepresented students (defined as those coming from underserved populations, underrepresented institutions, or communities underrepresented in the field of environmental health in terms of economic, racial/ethnic, or other demographic characteristic), who will have the opportunity to learn about the latest work being done in environmental health; to learn about efforts to address the health impacts of environmental exposures; to network with leaders in the field; and to present their own work in environmental health.